Effects of the Great Recession and its Aftermath on U.S. Fertility

PROJECT SUMMARY
This R03 will conduct secondary data analyses that will identify the causal effect of the Great Recession (GR)
and its aftermath on the fertility of successive birth cohorts of U.S. women. Our causal identiﬁcation strategy
will employ a strikingly simple but rarely used cohort discontinuity design. This strategy relies on comparisons
of births to women in adjacent birth cohorts, thus comparing, for example, births at age 25 that were conceived
during the GR among the cohort of women born in calendar year t (“treatment”) to births at age 25 that were
conceived just before the GR among the cohort of women born in calendar year t 1 (“controls”). Our analyses
will exploit the extremely large number and near-universal coverage of the more than 131 million births available
in U.S. natality microdata. Preliminary results, presented below, suggest strikingly heterogeneous effects of the
GR by age and cohort, with (1) little effect of the GR for the youngest and oldest cohorts of U.S. women, but (2)
negative effects of between 0.010 to 0.017 fewer births per woman for cohorts of U.S. women who were born
between 1980 and 1990 and who were thus between the ages of 19 and 29 during the GR. These preliminary
ﬁndings motivate our Aim 2 analyses of fertility in the aftermath of the GR—for example, whether the initial
negative but small effects of the GR merely delayed childbearing or instead resulted in small but continuing
decreases in the years following the GR. These “recuperation” analyses will again employ a cohort discontinuity
design contrasting the post-GR fertility of “treated” and “control” birth cohorts of U.S. women.
Our identiﬁcation strategy differs from that used in previous research, with the vast majority of such studies
identifying the effect of the business cycle on fertility using exogenous variation in unemployment or other
economic indicators often pooled across multiple recessionary and non-recessionary periods. Our strategy, by
contrast, can be used to identify effects speciﬁc to a particular recession, which may be especially relevant in
the case of the GR, given its duration and severity.
We will estimate the effect of the GR and its aftermath at aggregate, state, and county levels of analysis.
Findings from these analyses will speak to a variety of questions such as: (1) whether the GR had more
negative effects at particular ages or for particular race and ethnic groups; (2) whether fertility “recuperation”
was more likely in states and counties that rebounded more quickly in the period following the GR; or (3) if the
GR might have initiated a continuing decline in fertility for particular cohorts, demographic groups, or localities.

Public health relevance
PROJECT NARRATIVE This R03 will employ a strikingly simple but rarely used cohort discontinuity design to provide insight into how the Great Recession of 2007–2009 affected the fertility of successive birth cohorts of U.S. women. We will analyze a restricted-access version of natality data containing information from birth certiﬁcates on virtually all U.S. births. Findings from this study will contribute to our understanding of how the most severe economic crisis since the Great Depression of the 1930s affected family formation, adaptation, and well-being.